Text Messaging to Improve Hypertension Medication Adherence in African Americans

DESCRIPTION (provided by applicant): Uncontrolled high blood pressure (HBP) is a major public health concern and leading cause of cardiovascular disease worldwide. The HBP crisis is particularly onerous to African Americans as they are disproportionately more susceptible to HBP than non-Hispanic White Americans. Poor adherence to prescribed medication regimens is a major problem, as only about half of patients who have been diagnosed with hypertension adhere to prescribed medications. Mobile phones and text messages are becoming widely integrated into routine daily life and may offer a simple and non-labor intensive strategy for improving the quality of medication management through enhancing medication adherence. This proposed research will be conducted in two distinct phases addressing three specific aims. For Specific Aim 1 (Phase I), we propose to conduct focus groups with participants from our target population in order to obtain feedback to guide the development of a mobile phone text message system that seeks to improve adherence to antihypertensive medications. For Specific Aim 2 (Phase II), we propose to pilot test the newly developed text message intervention with a randomized controlled trial. For Specific Aim 3 (Phase II), we propose to ascertain participant perceptions of intervention effectiveness and satisfaction in order to guide further system refinement. In Phase I, African Americans with uncontrolled hypertension (n=24-32) will be recruited to take part in one of four focus groups that will help guide the development of the text message intervention. In Phase II, African Americans with uncontrolled hypertension will be randomized to receive usual care (n=30) vs. the text message intervention (n=30). The primary outcome in this pilot will be change in medication adherence at one month follow-up;secondary outcomes include change in medication self-efficacy and systolic and diastolic blood pressure at one month follow-up, as well as participant satisfaction with the text message intervention. The proposed research will utilize the Wayne State University (WSU) Center for Urban Studies to conduct high quality and professionally run focus groups, the WSU Division of Computing and Information Technology's Broadcast Message Service infrastructure for the delivery of text messages, the WSU Center for Health Research for statistical analysis and grant management assistance, and a diverse study team from a variety of disciplinary backgrounds at WSU. As a result, the proposed research leverages the considerable local resources to investigate an innovative and much needed intervention for this high-risk population. PUBLIC HEALTH RELEVANCE: Poor adherence to prescribed medication regimens is a major problem, particularly among African Americans with uncontrolled high blood pressure. Mobile phones and text messages may offer a simple and non-labor intensive strategy for enhancing medication adherence. Due to its reliance on technologies already adopted by individuals, this application seeks to develop and test an innovative, adaptable, and highly scalable text message intervention for improving medication adherence in our target population.

Public health relevance
Project Narrative: Poor adherence to prescribed medication regimens is a major problem, particularly among African Americans with uncontrolled high blood pressure. Mobile phones and text messages may offer a simple and non-labor intensive strategy for enhancing medication adherence. Due to its reliance on technologies already adopted by individuals, this proposal seeks to develop and test an innovative, adaptable, and highly scalable text message intervention for improving medication adherence in our target population.